Engineered RNA Modification Recognition

Abstract
Alida Biosciences Inc is developing a commercial platform for the analysis of the epitranscriptome, which is the
totality of chemical modifications applied naturally to RNA to regulate possibly all aspects of RNA biology:
transcription (mods are installed co-transcriptionally), translation, transcript lifetime, trafficking, alternative
splicing, RNA folding, RNA–protein interactions, and more. The field of epitranscriptomics has seen rapid growth,
motivated by the significance of this biology and the emerging opportunities to use RNA modifications as
diagnostic biomarkers and to intervene in epitranscriptomic pathways as a promising novel paradigm in drug
development, especially in cancer chemotherapy. Moreover, emerging evidence points to the significance of the
epitranscriptome in optimizing RNA-based medicines. Alida’s platform technology will make epitranscriptomics
accessible by offering a user-friendly workflow, integrated process controls, and cloud-based data handling and
bioinformatics. In this SBIR grant, we seek to integrate our engineered RNA modification binding agents into our
platform, develop and refine additional binders to expand the platform’s capabilities, and commercialize them in
v2.0 of Alida Bio’s EpiPlex assay. The enhanced properties of the novel binding agents are optimized specifically
for our platform to maximize sensitivity and selectivity, which is especially significant for high-value clinical
samples in which only sub-nanogram quantities of RNA are likely to be available: needle biopsies, FFPE
samples, and others. The high affinity and specificity of these binding agents will enable additional
biotechnological applications beyond EpiPlex.

Public health relevance
Project Narrative Alida Biosciences is a start-up company focused on reading the epitranscriptomic code, a regulatory layer of biological information controlling how the genetic code is used in cells when healthy and during disease progression. By creating and commercializing the first platform for reading multiple elements of this epitranscriptomic code simultaneously, we will enable new science to understand the progression of diseases such as cancer, identify novel diagnostic biomarkers, and accelerate drug development targeting epitranscriptomic pathways.